Clinical Prediction Tools for Head and Neck Cancer

Head and neck cancers are especially applicable for development in CSQS (now SEER Cancer Survival Calculator, or “SEER CSC”) because of significant co-morbidities and worse-than-average other-cause mortality among the diagnosed. This project will continue work on Head and Neck Cancer portion and consultation on all phases of use and usability of the SEER CSC.